Mentoring in patient-oriented research to finding a cure for HIV-1 infection

Abstract
Dr. Lichterfeld is an infectious disease physician-scientist with a strong record of mentoring research fellows in
high-profile, patient-oriented research studies related to HIV-1 cure and eradication. He conducts a broad and
diverse research program of patient-oriented studies that include molecular and cellular immunologic studies
with patient-derived cells, translational human investigations and interventional clinical trials designed to explore
novel therapeutic approaches to reduce HIV-1 reservoirs. These research activities provide attractive and
exciting training opportunities for physicians and scientists interested and invested in developing strategies for a
functional or sterilizing cure for HIV-1 infection; in the past, several of his mentees and co-mentees have
progressed to receive R-level funding, and have been offered independent faculty positions at highly-selective
universities around the world. In the proposed K24 application, Dr. Lichterfeld will extend and expand his
successful mentoring activities in the context of three cutting-edge research areas: He will mentor trainees in the
conceptualization, design, implementation and conduct of interventional clinical trials designed to explore novel
therapeutic strategies for HIV-1 eradication (Specific Aim 1). These activities will initially focus on an already
ongoing, NIAID-funded clinical trial in which Dr. Lichterfeld serves as the PI, but will be expanded in the future
to translate novel ideas and concepts into exploratory, proof-of-concept clinical trials. These studies take
advantage of advanced clinical trial research infrastructure and a highly motivated HIV-1 patient population at
the Brigham and Women’s Hospital and the Massachusetts General Hospital, the two hospitals Dr. Lichterfeld
is affiliated with. In addition, Dr. Lichterfeld will train his mentees in innovative next-generation sequencing and
proteomics approaches involving single-genome, near full-length viral sequencing, combined with viral
integration site analysis, chromatin accessibility assays and chromatin immunoprecipitation assays to profile
residual viral reservoirs in patient-derived cell samples at an unprecedented breadth (Specific Aim 2). This work
will be facilitated by unique technical resources and cross-disciplinary collaborations at the Ragon Institute and
the Broad Institute of MIT and Harvard, where Dr. Lichterfeld holds Associate Member status. Finally, Dr.
Lichterfeld will offer a distinct training experience in pediatric HIV-1 infection, focusing on the development of
interventions that may enable a long-term, drug free remission of HIV-1 infection in neonates from Botswana
(Specific Aim 3). These collaborative investigations will be performed in the context of ongoing, NIAID-funded
clinical trials investigating effects of standard antiretroviral therapy and broadly-neutralizing antibodies on viral
reservoirs and antiviral immune responses in HIV-1-infected infants started on therapy within the first days after
birth. Together, these studies provide distinct but interrelated training opportunities for physicians and scientists
to acquire the knowledge, skills, creativity and collaborations that are needed for an independent career in
patient-oriented studies focused on finding a cure for HIV-1 infection.

Public health relevance
Narrative Dr. Lichterfeld is an infectious disease physician whose research program bridges clinical, translational and basic science research studies for finding a cure for HIV-1 infection, and emphasize direct patient involvement and participation in research projects. In this K24 application, he proposes to expand his mentoring activities to train physicians and scientists in the design and conduct of clinical trials aiming for HIV-1 eradication, in studies to profile HIV-1 reservoir cells using novel technologies, and in investigations related to pediatric HIV-1 infection.